Displacement-guided focused ultrasound for pain modulation.

Over the past few years, focused ultrasound (FUS) has emerged as a promising noninvasive
approach capable of both stimulating and suppressing neuronal activity. Ultrasound has several
advantages over the aforementioned technologies as it can penetrate the brain over several
centimeters through the intact scalp and skull. Given its entirely noninvasive and nonionizing
nature, the technique has been shown to be translatable to human brain studies without requiring
introduction of electrodes or optical fibers. Similarly, FUS has been applied noninvasively on
peripheral nerves providing similar advantages. FUS works by modulating the neuronal tissue
region where the FUS beam is focused and could be combined with readouts that inform level of
activation. Several studies have shown that FUS can stimulate and/or suppress electrical and/or
hemodynamic activity in rodents, non-human primates (NHP) and humans, induce limb
movement, pupil dilation as well as suppression of somatosensory evoked potentials (SSEP) in
mice evoke anti-saccades in NHP and suppress pain sensation in humans. In sharp contrast with
its premise, however, and despite the multitude of advantages, FUS remains severely limited due
to the lack of intra-animal reproducibility, lack of targeting and monitoring methodologies during
modulation and its unknown underlying mechanism or targeted region. The true potential of FUS
remains diminished in its expedited adoption and therefore risks faltering on its premise. To this
purpose, our group has developed novel ultrasound-guided (USgFUS) capabilities with feasibility
shown in both CNS and PNS FUS modulation. In the proposed studies, we aim to harness those
methodologies developed to target regions critical for pain treatment. The methodologies
proposed could thus constitute breakthroughs in FUS modulation since they allow to selectively
focus (on the order of a few millimeters) and apply in shallow and deep-seated regions while
informing on the type of FUS mechanism in real time.. In the proposed R18 study, we aim to
harness the full potential of our novel monitoring system (MOTUS (MOnitoring of Transcranial
UltraSound)) to improve both safety and efficacy of FUS that can be used to both target and image
responses to both central (C-MOTUS) and peripheral (C-MOTUS) neuromodulation with FUS in
rodents and primates. The novel ultrasound-based methodologies proposed herein would
constitute breakthroughs in FUS modulation monitoring and allow for the first time accurately
targeting (on the order of a few millimeters) and steering across both shallow and deep-seated
regions (on the order of several centimeters in depth) as well as monitoring activity.

Public health relevance
Effective pain treatment remains a big challenge in healthcare. We propose to build and test two noninvasive and highly targeted devices that can modulate the brain or the peripheral nerve affected by pain focally and noninvasively while recording the subject’s responses in real time.